Improving Metabolic Stability Profiles in Kinase Inhibitor Development Through the Use of 1-Aminonorbornanes as Aniline Bioisosteres

Improving Metabolic Stability Profiles in Kinase Inhibitor Development Through the Use of 1-
Aminonorbornanes as Aniline Bioisosteres
Abstract
The proposed work focuses on the development of 1-aminonorbornanes and demonstration that these systems
can serve as metabolically-inert aniline bioisosteres. Toxicity profiles, particularly hepatotoxicity, requiring black
box warnings are common among FDA-approved tyrosine kinase inhibitors. Anilines, although they are
commonly used in the pharmaceutical industry, are often easily oxidized by CYP450s. Formation of reactive
intermediates upon oxidation often times leads to adverse drug-drug interactions and idiosyncratic toxicities.
Unfortunately, there are currently no clear isosteres for anilines, forcing medicinal chemists to continually use
these motifs despite the known proclivity to metabolism-derived off-target toxicity. A photochemical strategy to
readily synthesize 1-aminonorbornanes has been developed and published. Preliminary results suggest the 1-
aminonorbornane motifs occupy similar chemical space to anilines, despite their drastic structural difference.
These results have served as the initial proof-of-concept that the saturated carbocyclic framework of 1-
aminonorboranes can serve as a reliable aniline bioisostere. This preliminary evidence has optimally-positioned
this project to implement our synthetic designs and discoveries into disruptive translational advances. This will
be accomplished through the development of novel 1-aminonorbornane-based analogs of the oncolytic kinase
inhibitors, lapatinib and erlotinib. These isosteric analogs are anticipated to offer analogous anti-neoplastic
efficacy while avoiding the adverse metabolic events that have limited the utility of these and other cancer
chemotherapies. This work will thus validate the utility of 1-aminonorbornanes as aniline bioisosteres and provide
the momentum necessary to shift the drug development paradigm from risk-laden aromatic motifs to better-
tolerated, saturated building blocks.

Public health relevance
Improving Metabolic Stability Profiles in Kinase Inhibitor Development Through the Use of 1- Aminonorbornanes as Aniline Bioisosteres Project Narrative Though the majority of drugs undergo some form of metabolic processing upon entering the body, certain therapeutics can be converted to reactive intermediates that lead to adverse drug-drug interactions and idiosyncratic toxicities. The aniline functional group is notoriously susceptible to this issue; however, medicinal chemist still utilize these motifs, as there are currently no reliable, readily-diversified substitutes that occupy the same chemical space. The work proposed herein will demonstrate 1-aminonorbornanes are metabolically-stable aniline bioisosteres, and in doing so, we will provide a necessary blueprint for the design and development of better-tolerated and safer next-generation pharmaceuticals.